User-centered approach to the development of a parent toolkit to improve willingness to participate in pediatric clinical research

Abstract
Pediatric clinical trials are needed to improve the medicines and treatments available for children and
adolescents that are actually tested with youth rather than adults. However, recruitment barriers exist
including: not understanding the importance of clinical trials, fear of procedures and unknown in research,
mistrust in the research process, lack of knowledge about procedures, and worries about risks. Parents play an
important role in the decision about whether their child can participate in a pediatric clinical trial. Parents
need to be educated about clinical trials so that they can make an informed decision about participation and
effectively communicate with their child about the research opportunity. Although there exists websites and
YouTube videos that provide information on pediatric clinical trials, none of these resources provide parents
with skills or strategies to use when communicating with others and participating in shared decision-making.
Existing multimedia programs appear to only impact knowledge; however, changing attitudes and self-efficacy
to make decisions about clinical trials are also important factors that can influence parents’ willingness to allow
their child to participate in a clinical trial. With this R21, we aim to fill the gap in available resources for parents
by creating an
(English/Spanish language)
web-based parent toolkit for parents of children (ages 7-17), which
will provide information about clinical trials as well as provide opportunities for parents to practice and build
communication, information-gathering, and shared decision-making skills. It is hypothesized that by using the
web-based parent toolkit, parents will report an increase in their knowledge, positive attitudes, self-efficacy,
and willingness to participate in clinical trials, as well as decrease in mistrust and fear. In Year 1, we develop
the parent toolkit using a user/human-centered approach with feedback from multiple Advisory Panels of
parents (diverse in terms of ethnicity, race, gender, child age, and trust in research) and
Latino/a/x community
group members
, as well as toolkit review by expert consultants. The toolkit will be optimized for use on
computers, mobile devices, and tablets, and tested for Section 508 compliance, thus increasing the accessibility
and usability of the web-based toolkit. In Year 2, we will conduct a feasibility study with a sample of parents (N
= 150), who will complete self-report measures about their knowledge, attitudes, fears, self-efficacy, and
willingness to allow their child to participate in a clinical trial, as well as a consumer satisfaction questionnaire
to provide feedback on the toolkit. The results of the R21 will lay the foundation for the development of web-
based toolkit for parents that takes into account the perspectives of parents who are low in trust and familiarity
with clinical trials as well as parents that are diverse in ethnicity, race, gender, and age of their child. The
ultimate goal of this toolkit will be to increase the number of children and adolescents who are permitted to
participate in clinical studies, which is needed to improve treatments for pediatric illnesses and diseases.

Public health relevance
NARRATIVE A need exists for more pediatric clinical research to ensure that children are receiving appropriate medications, treatments, and devices that have been tested with children rather than adults. However, recruitment and retention in pediatric clinical trials remains a challenge. Parents play an important role in the decision-making process about their child’s participation in a clinical trial and a number of factors (e.g., awareness; knowledge; trust; fear) may inform their decision. Parents are in need of resources to help them better understand pediatric clinical research as well as facilitate high quality communication and shared decision-making skills related to their child’s participation in pediatric clinical trials. Thus, the goals of this application are to develop and test the feasibility of a web-based parent toolkit about pediatric clinical research (available in English and Spanish) using a user-centered approach that includes the voices from a diverse group of parents. This toolkit will have an impact on the field of pediatric health by providing parents with information and skills that are expected to increase pediatric clinical trial accrual.